A multimodal single-cell approach to developing personalized combinatorial treatments for glioblastoma

A major impediment to the treatment of glioblastoma (GBM) is its extensive intratumoral heterogeneity:
Each GBM tumor is heterogeneous with respect to genetics, immune microenvironment, and tumor cell
state. In particular, single-cell RNA-sequencing (scRNA-seq) has revealed that each GBM is a mixture of
different types of tumor cells, each with different biological properties, or cell states. Consequently, it may
be necessary to treat each patient with personalized drug combinations. Although scRNA-seq has enabled
us to understand the complexity of GBM, its clinical potential is largely untapped. This is partly because it
is difficult to physically isolate and study the cell types discovered using scRNA-seq. In previous work, we
showed that cell surface markers identified through scRNA-seq can be used to purify tumor subpopulations
using flow sorting. Building on this, we propose a novel approach to isolating GBM cell populations,
studying their therapeutic vulnerabilities, and identifying personalized drug combinations that target
multiple cell populations simultaneously. Our approach is based on CITE-seq (Cellular Indexing of
Transcriptomes and Epitopes by Sequencing), an extension of scRNA-seq that will enable us to efficiently
define tumor cell populations and isolate them using flow sorting. We will test the drug sensitivities of each
cell population, and then identify combinations of drugs that more effectively eradicate the tumor. This
approach will be developed through two Specific Aims: (1) We will isolate and characterize GBM
subpopulations using CITE-seq and flow sorting. Using our preliminary scRNA-seq data, we identified a
panel of candidate cell-surface markers for known GBM subpopulations. Using oligo-conjugated antibodies
to these putative markers, we will perform CITE-seq in primary tumors and matched cell lines to determine
which markers cleanly distinguish among tumor cell populations. Using the most promising markers, we
will test and optimize our ability to separate GBM samples into distinct subpopulations using flow sorting.
In doing so, we will test the hypothesis that there exist stable GBM cell states that persist after flow sorting.
(2) We will perform drug-screening on flow-sorted GBM subpopulations to identify personalized drug
combinations. To this end, we will isolate several subpopulations from each of five cell lines using flow
sorting, then test each subpopulation (as well as the flow-through and the unsorted cell lines) for sensitivity
to each of 960 FDA-approved drugs including temozolomide (current standard of care), and specific
combinations thereof. The resulting drug sensitivity matrix will be analyzed using clustering and machine
learning techniques to identify drugs that, when used in combination, will target multiple GBM
subpopulations and achieve greater efficacy than a single drug alone. If this approach is promising in pilot
experiments, we ultimately hope to expand and adapt it to the clinic, so that we can readily identify drug
combinations for any individual’s tumor.

Public health relevance
Glioblastoma (GBM) is the most common malignant primary brain tumor in adults, and carries a dismal prognosis that has improved little in recent decades. The goal of this study is to identify effective drug combinations tailored to the unique composition of each tumor by (1) identifying and isolating the distinct cell populations that comprise individual glioblastoma tumors, and (2) testing the drug sensitivities of each cell population. This approach has the potential to change the way this disease is studied and treated by establishing a pipeline for the identification of personalized, combinatorial drug treatments.